Center for Latino Health Research Opportunities-CLaRO - Administrative Core

Project Summary/Abstract
The Administrative Core of the proposed Center for Latino Health Research Opportunities (CLaRO) will oversee
and direct the infrastructure and collaborative community-engaged research and investigator development
activities of the Center. Within the innovative cross-institutional partnership between University of Miami (UM)
and Florida International University (FIU), CLaRO’s Administrative Core will facilitate coordination, integration,
and collaboration across all activities of the Investigator Development Core (IDc) and Community Engagement
and Dissemination Core (CEDc), including the CEDc Community/Scientific Advisory Board and early-stage
investigators (ESI) who participate in CLaRO training activities. Additionally, the Administrative Core will
collaborate with institutional and community partners and NIMHD to accomplish CLaRO’s overarching goals; the
Administrative Core will also lead CLaRO in leveraging the research and training infrastructure UM and FIU, and
associated NIH-funded centers, institutes, and programs, to further development and diversification of the health
disparities scientific workforce. The Administrative Core will ensure that CLaRO activities align with the Center’s
theme, advancing strategies in equitable implementation science to reduce health disparities in substance
abuse, violence/trauma, HIV/AIDS, and mental health (SAVA+MH) in vulnerable Latino communities in Miami-
Dade County, Florida. The Administrative Core has the following Specific Aims: Aim 1. Coordinate career
enhancement activities to facilitate research and investigator development related to the CLaRO theme. The
Administrative Core will coordinate the Pilot Projects Program and Research Enhancement Program as detailed
in the IDc Research Strategy. This Core’s role in IDc activities will consist of (1) administration, including fiscal
and logistical support, and (2) coordination of these activities within CLaRO and with other programs and
resources at UM and FIU. Aim 2. Coordinate Community Engagement/Dissemination of activities related to
Investigator Development Core. This will include: (1) Coordination of all meetings (e.g., CSAB meetings),
including fiscal and logistical aspects, and activities between individual CSAB members involvement in awarded
Pilot Projects, (2) facilitating meetings and activities that will lead to the effective dissemination of Pilot Project
research findings that engage community members, partnering organizations, service providers, and other key
community stakeholders, (3) coordinating dissemination to and access of the CSAB and other community
stakeholders to facilitate their participation in CLaRO Research Enhancement Program activities. The
Administrative Core will guide CSAB members and other key community stakeholders affiliated to CLaRO in
accessing the rich set of research resources available through CLaRO, our institutions, and our partnering
centers/institutes. This includes providing technical assistance to CSAB members and Pilot Awardees in
accessing social media resources and networks available at UM and FIU that will facilitate dissemination efforts.